Transferring Speed of Processing Gains to Everyday Cognitive Tasks after Stroke

ABSTRACT
This Diversity Supplement application is connected to funded grant R01 AG070049 (Title: Transferring
Speed of Processing Gains to Everyday Life; PI: E. Taub; Project Period: 9/5/2021- 8/31/2022). This
application requests funds to provide training in neurorehabilitation research to the proposed Diversity
Supplement candidate in association with the clinical study supported by the parent grant.
The purpose of the parent grant is to conduct a randomized controlled trial (RCT) to evaluate the
efficacy of a new treatment, Constraint-Induced (CI) Cognitive Therapy, for improving cognitive impairment in
patients with chronic stroke. CI Cognitive Therapy combines two repeatedly validated rehabilitation methods:
the Transfer Package of CI Movement Therapy and Speed of Cognitive Processing Training. The purpose of
doing so is to produce a marked enhancement in the transfer of cognitive improvement from the training setting
to instrumental activities of daily living (IADL) in everyday situations. Both halves of the new combination
therapy are founded on the investigators’ own basic research. In both cases, efficacy is supported by positive
results from multiple single-site RCTs and a large multisite RCT. However, the effect of Speed of Processing
Training (SOPT) has been found to have limited generalization to cognitive-based IADL in everyday situations.
In contrast, one of the main strengths of CI Therapy is that it produces a robust and extensive transfer of
treatment effect to everyday life situations by means, in part, of its Transfer Package (TP).
The parent grant involves a single-blind RCT with two arms: SOPT with the TP vs. SOPT without the
TP. Participants will be 120 adults more than 1-year post-stroke with mild to moderate cognitive impairment.
Performance on cognitive tasks will be measured in daily life and in the lab before and after baseline, after
treatment, and 6- and 12-months afterwards.
To expand the research skills of the Diversity Supplement candidate and foster her development as a
career as an independent scientist, this application proposes a two-year, structured program of didactic training
in grant writing and data analysis, hands-on training in the design and conduct of neuro-rehabilitation research,
independent research activity, manuscript and grant application development, and presentation of data at
scientific conferences.

Public health relevance
Project Narrative Impairment of information processing is a frequent consequence of stroke. Several interventions have been developed to address this impairment but the transfer of gains made in the treatment setting to everyday life and the retention of these gains is limited. The proposed research is designed to begin the process of evaluating a Transfer Package of behavioral techniques designed to result in: 1) transfer of gains achieved in the treatment setting to everyday life, and 2) result in retention of the real-world gains without decrement for at least 1 year.